Plan to Enhance Diversity

The overarching goal for Roswell Park's Plan to Enhance Diversity (PED) component is to promote and sustain
inclusive training, hiring, and career development processes using diversity, equity, and inclusion (DEI) best
practices. We will achieve this through purposeful and intentional assessment, program planning, resource
allocation, and evaluation activities to optimize and enhance the center's DEI infrastructure. Roswell Park
leadership has committed to a purpose driven strategic partnership approach to align and sustain DEI activities
and best practices across the organization. Broadly, our PED plan will enhance and expand infrastructure to
increase participation of women and individuals from groups historically underrepresented in the research
workforce, which includes trainees, faculty, research staff, and center leadership. Our specific aims cover the
priority areas identified in our PED logic model and address structural factors (e.g., cancer center infrastructure
and environment) and institutional level mechanisms (e.g., workforce development, pipeline programs, faculty
recruitment and retention) in a complementary manner. The PED team is collaborating with organizational
partners to implement DEI best practice strategies to mitigate bias and improve climate across the educational
and professional continuum extending to cancer care delivery.
Roswell Park's Plan to Enhance Diversity is driven by three aims: 1) Enhance diversity in faculty and center
leadership; 2) Enhance the educational, mentoring, and training infrastructure to support participation from
diverse and underrepresented populations; and 3) Develop and implement criteria for monitoring and evaluating
progress in diversity to support sustainability of diversity, equity, and inclusion best practices. This PED
component is led by Elisa M. Rodriguez, PhD, MS, serving as the inaugural Associate Director (AD) of DEI
since August 2022. Dr. Rodriguez is an Associate Professor, Population Sciences program member, and former
Chief Diversity and Equity Officer for Faculty, which provided valuable insight for the AD of DEI role.
The DEI office and PED component work together to support a holistic DEI approach across the cancer center
in collaboration with staff affiliated with Cancer Research Training and Education Coordination (CRTEC) and the
Office of Community Outreach and Engagement (COE). PED partners with COE to include the viewpoints of
diverse community stakeholders through multiple feedback pathways to ensure our DEI efforts are inclusive and
responsive to the needs and values of the catchment area and beyond. PED, COE, and CRTEC are and will
continue to be synergetic in their approaches to ensure alignment and integration of best practices, including
routinely sharing and reviewing qualitative and quantitative data to inform prescriptive activities that address
opportunities to enhance PED, COE, and CRTEC cancer center operations.